Elucidating the role of selective Golgi remodeling in cellular homeostasis

Project Summary/ Abstract:
Mammalian cells can tune spatial distribution of proteins and remodel the proteome in response to a myriad of
cellular stress conditions through protein production and degradation. Macroautophagy (autophagy), an
evolutionarily conserved degradation pathway, delivers cellular macromolecules to the lysosome for recycling1,2.
Autophagy in response to nutrient stress has long been considered to result in non-specific capture of
cytoplasmic contents within autophagosomes to generate biosynthetic building blocks3–6. However, recent work
revealed a pathway that enables the selective encapsulation and delivery of Golgi membrane proteins to the
lysosome for recycling upon nutrient stress (Golgiphagy), mediated by two Golgi-resident multipass
transmembrane proteins (YIPF3 and YIPF4)7. Thus, autophagy entails layers of selective organelle turnover
(principally Golgi and ER) rather than simply random cytosol encapsulation. Beyond nutrient stress, YIPF3/4-
mediated Golgiphagy also selectively remodels the Golgi proteome during in vitro neuronal differentiation,7,8,
suggesting a broad role for YIPF3/4 in regulating Golgi homeostasis. Despite this finding, the molecular
mechanism(s) that enable the selective degradation of Golgi proteins by autophagy, and the functional
consequences of Golgi remodeling on neuronal homeostasis remains completely unknown.
The proposed research aims to understand the molecular mechanisms that underpin Golgiphagy, and
the impact of autophagy, and other quality control pathways, on neuronal Golgi homeostasis. AIM 1 will elucidate
molecular mechanisms of YIPF3/4 mediated selective Golgiphagy and provide training in the biochemical
techniques necessary to purify, reconstitute, and dissect mechanisms of membrane proteins. AIM 2 will create
a 3D super-resolution Golgi protein map to uncover the impact of autophagy on establishing neuronal Golgi
protein organization and develop tools to rigorously investigate Golgi biology in neurons. Finally, the independent
phase of this award, AIM 3, will uncover Golgi quality control pathways using systematic assays, followed by
mechanistic dissection of the underlying mechanisms, using the knowledge and tools developed during the
mentored phase of this award. Understanding the pathways of Golgi quality control in neurons will provide
insights into the connection between Golgi dysregulation and neurodegenerative disease.
The mentored phase of this award (AIM 1-2) will provide both biological and technical skills that will be
essential for the PI’s success as an independent investigator, including AIM 3 of this application. The mentored
phase of this award provides the opportunity to work with leaders in the fields of Golgi biology and neurobiology
to acquire the training needed to achieve the PI’s long-term goal of becoming an independent investigator at the
interface of both fields. Together, the proposed research, mentorship team, and resources provided for career
development at Harvard Medical School will provide the training needed to achieve the defined career goals.

Public health relevance
Project Narrative: Golgi dysregulation is associated with a myriad of neurodegenerative diseases, suggesting that Golgi homeostasis is essential for neuronal function. The proposed research will employ multiple systematic techniques to comprehensively identify Golgi quality control pathways, such as autophagy, that ensure the maintenance of Golgi homeostasis, followed by biochemical dissection of the underlying molecular mechanisms. Understanding the fundamental pathways that protect Golgi homeostasis in neurons will provide insights into the molecular etiology of neurodegenerative diseases and enable the development of future therapeutics.